IGF::OT::IGF NEXT - DNA METHYLTRANSFERASE-TDCYD TO#3 CONDUCT STUDIES $234,760 RAT (NX157-110-187-003) & $478,298 DOG (NX157-110-187-004) PRE-CLIN TOX STUDY OF DRUG DEV FOR CANCER PATIENTS HHSN26120160

The test agent is being considered for development as an anticancer therapeutic. The objective of this task was to characterize the target organ toxicities of an investigative agent that might move forward to clinical testing for anticancer activity. The information obtained from this investigation was used to identify drugs with the potential to treat cancer.